Children's Exposure to Indoor and Outdoor Air Pollution within the SHEAR Project in Rwanda

Abstract:
More than four million people die each year from exposure to outdoor air pollution and nearly the same number
perish from indoor exposure to dirty fuels. Despite the largest burden of disease being in developing countries,
the vast majority of literature has focused on wealthy nations and there is a particular absence of high-quality
authorship on sub-Saharan Africa. Children are highly susceptible to air pollution health impacts due to their high
breathing rates, developing lung structures and immune systems; they are thus a population of particular interest
when assessing the impacts of air pollution. This is not currently possible in sub-Saharan Africa region due to a
lack of scientific understanding of the sources, causes and impacts of air pollution, inefficient data collection and
analysis, weak air quality standards, and inadequate funding for air quality monitoring stations. Most studies on
the health effects of air pollution on children have used exposure estimates from home locations; only a small
number have tested the association between outdoor air pollution levels measured inside and outside of
households and a range of children’s health outcomes, thus limiting the information on the extent to which indoor
and outdoor air quality affect each other. I propose here a research and career development plan to study
children’s exposure to air pollution in rural Rwanda and to address these knowledge gaps. The overall aims of
the research is to develop a network of low-cost monitors for fine particulate matter (PM2.5) air pollution in rural
Rwanda (Aim 1) and In conjunction with exposure data collected from the SHEAR trial (described below),
examine the extent to which both outdoor and indoor pollution sources contribute to children’s exposure to PM2.5
(Aim 2). This research, conducted over 3 years will synthesize current data and knowledge using field
measurement, modelling, surveys and multivariate analysis. The proposed project aligns well with the
Sustainable Household Energy Adoption in Rwanda (SHEAR) Project (led by my mentoring team), which I will
leverage for this K43. I will create a monitoring network and evaluate indoor/outdoor relationships using eligible
households within with SHEAR project. Simultaneous personal (children’s) and household level measurements
of exposure to PM2.5 will take place over a 3-year period (reflecting repeated measures by season). Chemical
speciation of collected PM2.5 will (organic and elemental carbon, metals, ions) will allow pollution exposures (at
the community, household, personal level) to be apported to various indoor/outdoor sources (i.e., vehicle
emissions, road dust, biomass smoke).This research study will result in the publication of three peer-reviewed
papers and a policy focused- report to the Rwanda government. This work will enable me to work directly with
Drs. John Volckens and Maggie Clark, Professors at Colorado State University (CSU) and Dr Theoneste
Ntakirutimana, Professor at the University of Rwanda, recognized experts in air pollution, exposure science,
epidemiology, public health. The trainings activities will include (1) Engineering / sensor development; (2) Data
Science and statistics ;(3) Epidemiology and health effects; and (4) Health communication.

Public health relevance
Narrative Children are both vulnerable to air pollution exposure and more susceptible to adverse health effects from such exposure. The proposed study would be the first to explore the dual role of indoor/outdoor air pollution exposure and risk in Rwandan children while also considering the composition of measured pollutants. Such research is beneficial because it can more accurately demonstrate the health risks in vulnerable populations while simultaneously direct interventions that target dominants sources of hazardous air pollutants and will explore different intervention and mitigation strategies to reduce exposure, leading to the development of clear policy recommendations